Investigators from Novices, a Transdisciplinary Research Education Program to Increase Diversity (INTREPID) in Aging Research

PROJECT SUMMARY/ABSTRACT
To create a representative paradigm on aging, research participants need to include individuals from
underrepresented populations. Overall, the percentage of the US population of adults aged 65 years and older
is expected to nearly double by 2060 while those 85 years and older will almost triple in the same time frame.
Similarly, the overall US population percentages, based upon race and ethnicity are expected to increase for
people declaring only Black/African American, Hispanic, and Asian. Throughout the lifespan, differential health
gaps and disparities by race and ethnicity are readily identified in the morbidity and mortality data for
communicable and non-communicable diseases. To fully understand and address the complexities of aging
among the growing minority population in the US, research studies need to determine the underlying
mechanisms contributing to the identified health disparities, and test culturally appropriate interventions. One
suggested solution to ensure these imperatives are met is to increase the numbers of minority researchers
who engage in aging research. Researchers from underrepresented groups that share experiential similarities
with study participants, improve the quantity and quality of research engagement by participants, and provide
critical insight to more accurately shape an inclusive aging paradigm. However, MSTEM scientists are not
racially or ethnically representative of the general population. In order to increase minority researchers in aging
and to fully understand the complexities of aging among the growing minority population in the US, we propose
an intervention tailored to support MSTEM students from racial and ethnic groups, individuals with disabilities,
individuals from disadvantaged backgrounds, and women in biomedical disciplines with disproportionately low
numbers of women. Investigators from Novices, a Transdisciplinary Research Education Program to Increase
Diversity (INTREPID) in Aging Research will move the students toward engaging in aging research. Framed by
Tinto's model on student persistence in college, INTREPID will provide MSTEM-students a supportive
environment for their successful undergraduate completion, and pursuit of a graduate research degree.
Curriculum based on the NIA Health Disparities Research Framework, offered over two summer institutes of
45 hours each will promote student affinity toward older adults and provide a foundation for their engagement
in the research process. Faculty from the University of Central Florida's transdisciplinary Disability, Aging and
Technology (DAT) Cluster will provide a mentor-mentee matched hands-on research experience that has
linkages to the student's MSTEM major, and establishes and builds the student's identity as a scientist. The
measurable outcomes of INTREPID aim to increase the number of underrepresented and disadvantaged
students who, gain an identity as a scientist, complete their undergraduate MSTEM degrees, and advance to
graduate research programs to prepare them to study health disparities in aging.

Public health relevance
PROJECT NARRATIVE MSTEM scientists are not representative of race, ethnicity, gender, disability or socioeconomic status demographics in the general population. In order to increase underrepresented and disadvantaged researchers in aging and to fully understand the complexities of aging among the growing minority population in the US, the proposed program, Investigators from Novices, a Transdisciplinary Research Education Program to Increase Diversity (INTREPID) in aging research, will provide MSTEM-students an environment that promotes student affinity toward older adults, opportunities for research experiences, and support for successful undergraduate completion, and pursuit of a graduate research degree. Having underrepresented and disadvantaged researchers in aging will have the potential to increase understanding of the relationship between health disparities and aging, and the development of interventions to improve the health of all older adults.